Core A: Single Cell Profiling and Bioinformatics Core

Project Summary/Abstract
The Single Cell Sequencing and Bioinformatics Core (Core A) is designed to support all Program Projects in
their studies of how external, modifiable risk factors influence the progression of clonal hematopoiesis to
hematologic malignancy in mice and humans. Two major themes of the Program – understanding how cells with
specific mutations respond to modifiable stressors and evaluating the impact of individual mutant clones on
others in the ecosystem – both depend on single-cell analysis of cells. The mission of this Core is to provide
advanced technical and analytical platforms to track and characterize human and murine mutant cells at single-
cell resolution, followed by bioinformatics and mathematical analyses necessary to interpret the data. The Core
will (1) provide high-throughput single-cell genomic analysis and other advanced sequencing platforms to all
Projects; (2) will provide bioinformatics analysis of multi-dimensional datasets and facilitate data sharing; and (3)
will develop mathematical modeling based on large-scale molecular data from mice and humans. To support the
first aim, the core is equipped with various single-cell genomics platforms such as Chromium (10X Genomics)
and Tapestri (Mission Bio), which enable high-throughput single-cell RNA and DNA sequencing, as well as
single-cell multi-omics approaches (CITE-seq and simultaneous DNA/protein analysis). Dr. Koichi Takahashi,
Leader of the Core, has been on the forefront of use of such technologies in evaluating the evolution of
hematologic malignancies, making him ideally suited to lead to this Program-specific Core. In the second aim,
the Core will provide necessary bioinformatic support in analyzing large-scale epigenetic and transcriptomic data
in response to modifiable extrinsic risk factors (infection and obesity in Project 1; chemotherapy and smoking in
Project 2) to understand the biological effects of stress on clonal hematopoiesis and malignant transformation.
In the third aim, the Core will utilize broad epidemiologic data to develop a mathematical model to predict the
risk that CH progresses to frank hematologic malignancy in individuals based on their genetic variants, clone
size (as measured by variant allele frequency), and specific exposures to modifiable external risk factors (e.g.
smoking, obesity, infection, chemotherapies). Dr. Marek Kimmel, Co-Leader of the Core, has an extensive
background in mathematical modeling of stem cell dynamics and cancer and is well-positioned to lead this aspect
of the Core. This Core will coordinate data storage and quality controls (QC) to ensure the rigor and
reproducibility of the data and facilitate public data sharing. Overall, Core A will provide cutting-edge technical
and analytical support for all three proposed Projects and support statistical rigor and reproducibility, with support
from Core B. By centralizing data analysis and storage, this Core will facilitate the integration of datasets and
cross-sectional analyses in order to optimize crosstalk between the large-scale mechanistic animal and human
epidemiology studies in this Program. The work of this Core is central to the Program’s overall goal of elucidating
the mechanisms of clonal dynamics in response to modifiable external stressors.

Public health relevance
Project Narrative The Single Cell Sequencing and Bioinformatics Core (Core A) will provide all Projects with technical and analytical platforms and bioinformatic support to enable lineage tracing and measure molecular responses of both human and murine mutant cells at single-cell resolution. In addition, this Core will use the large-scale epidemiologic data from Project 3 to develop a mathematical model to predict the risk that clonal hematopoiesis transforms into frank hematologic malignancy in older adults. This Core is critical to understanding how cells with specific mutations respond to various modifiable stressors and thus the overall mission of this Program.